Administrative Supplement: Molecular mechanisms that regulate vesicle formation and transport

Project Abstract
See Research Strategy. No changes.

Public health relevance
Project Narrative Not applicable - no changes.